Upgrade of core imaging instrumentation and robotics for the UCSC Chemical Screening Center

We request an integrated platform of robotics and instrumentation to update the UC Santa Cruz Chemical Screening Center (CSC), a shared research facility that has supported NIH-funded biomedical research at UC Santa Cruz since its inception in 2007. Research conducted at the CSC addresses a range of biomedical questions, including investigations of the circadian clock, host-pathogen interactions, the cell cycle, RNA splicing, tropical diseases such as African River Blindness, and development of methodologies for natural products discovery. Activity in the CSC has resulted in well over 50 peer-reviewed publications, most of which were jointly authored by faculty from different departments and specialties, and many grants have been funded based on preliminary data acquired at the CSC. HTS is central to the discovery of bioactive small molecules, either as drug leads or biological tool compounds. As the cost of liquid handling robotics and chemical libraries has declined during the past decade, HTS has become a powerful discovery tool for the academic research laboratory. While the CSC is an important shared research facility at UCSC with strong administrative support, bottlenecks exist in its current configuration that limit its potential impact on key NIH-funded projects. After 13 years of constant operation, the core liquid handling instruments in the CSC are becoming unreliable and are in need of replacement. The proposed microscope provides much better image quality, faster acquisition times, and more efficient image analysis software to the growing user base at UCSC who depend on image-based screening for their research. As interest in small molecule approaches has grown among the NIH-funded biomedical community at UCSC, we must improve the efficiency, and accuracy of our screening instrumentation. Modernizing our automated liquid handling system will not only allow the CSC to continue operations at the current throughput, but will transform the facility by enabling screening in 1536-well plates, thereby enabling the screening of a larger replacement library of 100,000 small molecules, which UCSC has offered to purchase as part of the Institutional Commitment to this proposal. Indeed, the Institutional Commitment is very strong, supporting two full-time employees for at least 5 years following installation, plus a contingency plan to ensure uninterrupted operation of the facility in the unlikely event of a budgetary shortfall. In short, the UCSC-CSC has facilitated exciting discoveries in a wide array of biological systems, many with direct therapeutic applications, and the proposed upgrade will allow this important facility to continue catalyzing NIH-funded scientific advances for years to come.

Public health relevance
We request an integrated platform of robotics and instrumentation to update the UC Santa Cruz Chemical Screening Center (CSC), a research facility that uses automation technology to rapidly screen thousands of chemicals for potential drugs against cancer, bacteria, and neglected tropical diseases. The CSC has been in operation since 2007 and has facilitated a variety of important biomedical discoveries. The proposed equipment will replace the aging screening infrastructure in the CSC, dramatically increasing its potential impact on important problems relevant to human health and our understanding of basic biological processes.